Myovascular Mechanisms of Cardiac Growth and Regeneration

ABSTRACT:
We, and others, have determined that cardiomyocyte (CM) proliferation is dependent on cardiac endothelial
cells (CECs). Proliferating CECs are spatiotemporally coupled to proliferating CMs in the neonatal mouse
heart; loss of CECs leads to decreased CM proliferation; and higher levels of the master angiogenic factor
Vegfa promote cardiac growth in zebrafish, neonatal mice, and humans. Based on these studies, our
overall hypothesis is that activated, proliferating CECs instruct CM proliferation. Here, we propose studies
to determine how CECs promote CM proliferation. We will use scRNA-seq and spatial modeling to identify
the specific subset of CECs physically associated with proliferating CMs; we will determine how Ezh2-
mediated chromatin remodeling coordinates CEC activation with CM proliferation; and we will define the
potency of CEC-induced growth factors to stimulate CM proliferation. This work will result in new cellular,
epigenetic, and paracrine mechanisms for CEC-induced cardiac growth and has high potential to inform
methods for therapeutic heart regeneration.

Public health relevance
PROJECT NARRATIVE We have determined that vascular cells in the heart are critical to heart regeneration in neonatal mice and zebrafish. This proposal seeks to define the mechanisms that vascular cells use to promote cardiac growth. Our work can inform methods for therapeutic heart regeneration, which can be used to treat human cardiovascular diseases including heart failure.